T cell receptor-activated autophagy as a regulator of T cell effector responses

Project Summary/Abstract Engagement of the T cell receptor (TCR) initiates a complex cascade of stimulatory and regulatory signals that orchestrate highly precise control of T cell proliferation, survival and differentiation. We have recently defined TCR-induced autophagy (TCR-IA) as a novel mechanism that regulates TCR signal transduction via highly selective degradation of key signaling molecules. We have shown that TCR-IA is independent of Vps34, the class III phosphoinositol-3-kinase (PI3K) implicated in most autophagy pathways. Our preliminary data suggest that TCR-IA is dependent on class I PI3K and inositol phosphatases, including SHIP1/2 and Inpp4A/B. In studies of the terminal steps in TCR-IA, we have demonstrated that the selective targeting of T cell signaling intermediates to autophagosomes requires a cytoplasmic signaling complex we have named the “POLKADOTS signalosome,” in which the multi-functional adaptor molecule p62 plays a central role. Our recent data show that the signaling adaptor, Bcl10, is targeted to the TCR-IA degradative pathway via interaction with p62. We have also shown that degradation of the cyclin dependent kinase inhibitor, p27, requires p62 expression, suggesting that p62 is a crucial component of a molecular machine (the POLKADOTS signalosome) that directs TCR-IA-dependent proteolysis of specific targets. The purpose of our proposed studies is to elucidate the molecular mechanisms that connect antigenic stimulation of the TCR to selective degradation of targets of TCR-IA, and to determine the consequences of disruption of terminal steps in this pathway on T cell effector differentiation and function. We will achieve these goals through three Aims. The goal of Aim 1 is to define the cytoplasmic signaling pathway by which TCR signaling leads to de novo production of autophagosomes, with a particular emphasis on SHIP1/2 and Inpp4A/B. Our studies in Aim 2 will determine the molecular mechanism by which p62 and POLKADOTS signalosome partners direct TCR-induced selective autophagy of target molecules. In Aim 3, we will use an inducible p62 knockout model to determine the role of p62 and p62-dependent TCR-IA in generation of in vivo T cell effector responses. Together, we expect these data to define key molecular mechanisms in the TCR-IA pathway, and to define how TCR-IA impacts T cell differentiation for control of pathogen infections. This work may ultimately lead to novel and highly specific strategies for manipulation of in vivo T cell responses, which may be applicable to diverse human diseases such as autoimmunity, transplant rejection, and cancer.

Public health relevance
Project Narrative We have recently demonstrated that TCR-induced autophagy (TCR-IA) as a novel mechanism that regulates TCR signal transduction via highly selective degradation of key signaling molecules. Our preliminary data suggest that TCR-IA is dependent on a novel signaling pathway, distinct from known pathways of autophagy induction. Through elucidation of crucial mechanistic steps in this pathway, we expect to identify novel strategies to manipulate T cell activation and differentiation, which may ultimately lead to novel therapeutics for cancer, autoimmunity, and graft rejection.